Circulating Plasma Metabolites, Lifestyle Factors, and Mortality Risk

PROJECT SUMMARY/ABSTRACT
Recent advances in high-throughput metabolomic studies have shown promise in elucidating potential pathways
underpinning aging processes and longevity. However, data in human populations are still constrained by small
sample sizes and a limited number of metabolites profiled. Existing studies have also not integrated data on diet
and lifestyle to evaluate the associations of interest in a comprehensive manner. A better understanding of aging-
related metabolic alterations and whether metabolite profiles are modulated by lifestyle factors is crucial to
develop effective strategies to promote health and well-being. The main goal is to identify novel metabolite
profiles associated with mortality and prolonged longevity, and investigate whether the metabolomic signatures
of lifestyle factors are associated with mortality and longevity. We propose to leverage unique resources from
two large U.S. cohorts with long follow-up and extended lifespan data: the Nurses’ Health Study (NHS) and the
Health Professionals Follow-Up Study (HPFS) (n~8,100). The results will be replicated in two independent
populations: the Women’s Health Initiative (WHI) (n~2,300), and the Prevención con Dieta Mediterránea
(PREDIMED) Study (n~3,000), a population at high cardiovascular risk in Spain. This research application is
aimed at: (1) identifying plasma metabolomic profiles and networks associated with mortality and longevity; and,
(2) identifying the metabolomic signatures of a healthy lifestyle score and examining its prospective association
with mortality and longevity. The proposed project is built on the numerous strengths of existing cohort studies
in U.S. and Mediterranean populations, and supporting results from the preliminary work conducted by our multi-
disciplinary team. Findings from this study will provide insights into the underlying mechanisms of longevity and
advance our understanding of how plasma metabolomics may mediate the associations between lifestyle factors
and mortality risk. The proposed research will generate new knowledge that can directly inform specific lifestyle
interventions applicable in clinical settings to improve the health and well-being of adults as they age. The
proposed research will provide a wealth of preliminary data to stimulate further research on longevity and healthy
aging.

Public health relevance
PROJECT NARRATIVE We propose to leverage unique resources with longitudinal data to identify metabolite profiles and networks associated with total mortality and longevity, and investigate whether the metabolomic signatures of a healthy lifestyle score are associated with the risk of mortality and longevity, in U.S. and Mediterranean populations. This study has the potential to identify novel metabolic signatures of both mortality and longevity and improve our understanding of how lifestyle factors modulate metabolites and mortality risk, which can help to design better preventive and intervention strategies.